Society for Research on Nicotine and Tobacco 2024 Annual Meeting

PROJECT SUMMARY
The Society for Research on Nicotine and Tobacco (SRNT) is the only international scientific society
dedicated exclusively to the field of nicotine and tobacco research. SRNT has more than 1,100 members from
over 40 countries, with approximately 85 percent of those members being affiliated with U.S. institutions,
including universities, Federal agencies, research and related organizations. The overall objective of the SRNT
is to stimulate advancement in the field of nicotine and tobacco research through the presentation of timely and
cutting-edge research, discussion, and networking; this objective is largely carried out through presentation of
1,000+ papers/posters/symposia/plenary lectures at its Annual Meeting. It is the hallmark conference in the
field where investigators, advocates, and policymakers can learn about the latest scientific findings, including
novel products in the marketplace and effective interventions and policies to reduce tobacco use in the U.S.
and in other countries. The SRNT Annual Meeting provides a crucial venue for the presentation of the rapidly
evolving tobacco regulatory science research findings to the major keyholders in research and policy. The aims
of this conference grant are to: 1) ensure that tobacco regulatory science content is presented in ways that are
maximally informative to FDA and to researchers in the field; and 2) to support the career of trainees and early
career investigators in tobacco regulatory science via opportunities for special oral sessions, professional
development forums, travel awards, and other recognition. To meet both aims, SRNT’s Program Committee
will meet regularly throughout the year to plan the content and format of the SRNT 2024 Annual Meeting,
aligning the presentation of scientific content with research priorities in the Tobacco Regulatory Science
Program (TRSP). The Committee will curate paper sessions on specific topics that highlight advances in the
area, foster scientific discussion and debate, and stimulate collaboration across researchers. The conference
grant will also support 10 travel awards for trainees and early career investigators presenting on content
related to the FDA and NIH Tobacco Regulatory Science Program research priorities. These interactions will
facilitate the development of novel questions and approaches to tobacco regulatory science research and
support the careers of future researchers in tobacco regulatory science.
Although 85% of SRNT members are based in the US, SRNT is an international membership
association. Therefor the Annual Meeting must be held outside the US periodically; the last non-US Annual
Meeting was held in 2017. While the 2024 Annual Meeting will take place in the UK the vast majority of
attendees and presenters will be from the United States as is the case every year. Furthermore, all conference
planning including abstract submission system development, management, and execution; Program
Committee support and Program development; website and mobile app development; online hosting of
sessions presented; grant and finance management; graphic design; and all other logistical arrangements
have been and will be managed exclusively in the US by SRNT’s management company, The Rees Group,
Inc, a small business in Madison, WI. No grant funds will be paid to any non-US vendor or company, and only
US residents will receive travel grants funded by this R13.

Public health relevance
PROJECT NARRATIVE The SRNT 2024 Annual Meeting is the optimal venue for the presentation of novel findings from tobacco regulatory science research projects and networking across scientists in this emerging field. The aims of this conference grant are to: 1) ensure that tobacco regulatory science content is presented in ways that are maximally informative to FDA and to researchers in the field; and 2) to highlight the work of trainees and early career investigators in tobacco regulatory science via special oral sessions, professional development forums, travel awards, and other recognition.